Mentoring in patient-oriented research in social determinants and atrial fibrillation

Oral anticoagulation is a foremost, guideline-based priority for stroke prevention in individuals with atrial
fibrillation (AF), a common condition with high social and medical costs. Social determinants of health (SDOH)
contribute to accessibility of anticoagulation and the long-term adherence necessary for stroke prevention. This
patient-oriented mentoring research program will (1) examine the relations of individual- and neighborhood-
level social factors with oral anticoagulation, and (2) accelerate an innovative health services mentoring
program in SDOH and AF and cardiovascular disease. SDOH have had limited investigation in AF, such that
the investigations described here will inform how SDOH contribute to disparities in anticoagulation. The
investigations build on and leverage the core infrastructure of an active, funded health services research
program, the resources of a large, regional health care system, and the availability of large, highly
generalizable administrative health claims data. The specific investigatory aims are: (1) Evaluate
neighborhood-level SDOH in relation to anticoagulant adherence as measured by proportion of days covered
(PDC). This aim will add geocoding to two actively recruiting clinical trials (n=504) which aim to improve
adherence to anticoagulation in individuals with limited social resources. (2) Relate neighborhood-level SDOH
to anticoagulation. Employing the extensive electronic health record of the University of Pittsburgh Medical
Center, the analysis will examine associations of neighborhood-level SDOH with anticoagulation prescribing in
individuals with AF in a large, socially heterogeneous region. (3) Examine SDOH in relation to anticoagulant
prescription and 1-year adherence in a large administrative database. We will employ Optum Clinformatics to
examine individual-level SDOH in relation to PDC from 2015-2021. These investigations will be conducted in
the framework of a well-established mentoring program and build on the PI's active mentoring capacity in the
Schools of Medicine and Public Health at the University of Pittsburgh. Mentoring activities expand the
candidate's role with NHLBI-funded T32 training programs, the University of Pittsburgh cardiology fellowship,
internal medicine residency, and pre- and post-doctoral students in the School of Public Health. The project (1)
leverages multidisciplinary mentoring opportunities within the University sponsored by the Clinical and
Translational Science Institute (CTSI); (2) bolsters mentorship in conduct and design of clinical trials; and (3)
extends and broadens the applicant's demonstrated commitment towards mentoring and retention of
individuals from groups historically underrepresented in medicine. In summary, the award program will
enhance evaluation of SDOH in cardiovascular disease, health services research with large-sized
administrative data, and capacities for robust academic, research, and clinical mentoring. This application
proposes innovative research in SDOH and cardiovascular disease alongside career development activities for
substantive progress and achievement as a mentor in patient-oriented research.

Public health relevance
Social determinants of health increase the morbidity of atrial fibrillation. This study will examine how individual- and neighborhood-level social factors relate to access to anticoagulation – an essential medication for individuals with atrial fibrillation – and its adherence. The project will support robust mentoring in patient- oriented, health services research for junior clinical investigators focusing on social determinants and cardiovascular disease.